Personalized Modeling of CAR-T Cell Immunotherapy Using iPSC-Derived Effectors and Patient- Derived Tumor Organoids

Project Summary
Chimeric antigen receptor (CAR) T cell therapy has transformed the treatment of hematologic malignancies but
remains largely ineffective in solid tumors due to tumor heterogeneity, immune evasion, and the lack of
physiologically relevant preclinical models. To address this gap, we propose to develop a personalized in vitro
platform that combines tumor organoids derived from patient tumor tissues with CAR-T cells generated from
induced pluripotent stem cells (iPSCs). This system will enable functional modeling of CAR-T cell activity,
exhaustion, and tumor response in a patient-matched, autologous context.
We will derive iPSCs from normal tissue adjacent to resected tumors, differentiate them into CD8+ T cells, and
engineer them with tumor-targeting CARs. Tumor organoids from matched patients will be established through
the Rutgers Cancer Institute Organoid Core, characterized for antigen expression and immunomodulatory
features, and integrated into co-culture assays. Following co-culture, CAR-T cells will be evaluated for phenotype,
cytotoxicity, cytokine production, and expression of exhaustion markers. The co-culture platform will allow real-
time assessment of tumor cell killing, T cell activation/differentiation status, immune evasion, and
microenvironmental interactions.
This project addresses key goals of the NCI’s model development initiative by creating a scalable, autologous
tumor-immune model for evaluating immunotherapies. The resulting platform will support translational discovery
and the development of precision immunotherapies for solid tumors.

Public health relevance
Project Narrative This project aims to develop a patient-specific co-culture system that combines iPSC-derived CAR-T cells with tumor organoids to model immune-tumor interactions in vitro. The platform will enable functional evaluation of CAR-T efficacy and resistance mechanisms in a personalized context. Insights gained will advance precision immunotherapy and support the development of more effective immunotherapies for solid tumors.